Global Transcriptional Analyses of Fibromodulin Reprogrammed Cells - A New Multipotent Cell Source for Craniofacial Tissue Reconstruction

PROJECT SUMMARY / ABSTRACT
Regeneration of damaged craniofacial tissue is extremely difficult and often unsatisfactory due to insufficient
endogenous precursor cells as well as a corresponding finite regenerative capability. Furthermore, inherent
tumorigenicity and/or tumor supporting properties render the currently available pluripotent and multipotent cells
unsuitable for tissue regeneration, especially for craniofacial tissues. Thus, the production of safer and readily
available cell sources for functional craniofacial tissue regeneration remains a major challenge for regenerative
medicine, and particularly for craniofacial reconstruction. In response to this demand, we established a novel
technology platform in which dermal fibroblasts acquire multipotency by continuous exposure to an extracellular
matrix (ECM) proteoglycan, fibromodulin (FMOD), under serum-free conditions. Importantly, although both
FMOD reprogrammed (FReP) cells and induced pluripotent stem cells (iPSCs) express similar pluripotent
markers and hold the triploblastic differentiation potentials, their respective tumorigenic potencies are entirely
different, which could relate back to the fundamentally disparate methodologies for reprogramming dermal
fibroblasts into FReP cells or iPSCs. Unlike iPSCs generated through oncogene activation, FReP cells are
reprogrammed through a simple ECM stimulation procedure that does not require genome integration or
oncogene activation. It is worth noting that low tumorigenicity is a prerequisite for using a potential cell source in
skeletal muscle regeneration (an essential component of craniofacial disorder and trauma reconstruction) since
the highly vascularized microenvironment of the muscle compartment can be especially conducive to tumor
formation. Indeed, intramuscular implantation is a common route for teratoma formation when testing for cellular
pluripotency. Therefore, FReP cells appear to be a potentially safe and effective cell source that can be
adequately obtained for functional tissue regeneration. However, compared with mesenchymal stem cells
(MSCs) and iPSCs, FReP cells’ investigation is still in its infancy. A further comparison of the publicly accessible
transcriptomic data between FReP cells and iPSCs will provide more understanding into FMOD reprogramming
and the cell signal pathways that orchestrate the cell fate determination and tumorigenesis. In this study, we will
perform an in-depth transcriptomic profile to confirm the non-tumorigenic nature or FReP cells is independent of
the sex and age of their parental fibroblasts (AIM 1) and track the transcriptomic alteration of bioenergetic-related
genes during FMOD reprogramming to gain insight into a novel strategy to advance this technology (AIM 2).
Completing these AIMs will enrich our knowledge about cell fate determination and reprogramming, and
tumorigenesis, thus building the fundamentals for future investigations in the R01 stage. Therefore, the current
study will directly benefit the development of FReP cell-based therapies for the craniofacial or
musculoskeletal reconstruction and regenerative medicine in general. As such, this proposal is tightly
aligned with the mission of the current NIDCR R03 grant.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Fibromodulin (FMOD) reprogrammed (FReP) cells are a promising safe, and effective multipotent cell source that can be applied to craniofacial tissue regeneration, for which the outcomes are often unsatisfied due to the lack of adequate precursors with sufficient regenerative capacity. In this study, we will perform an in-depth transcriptomic profile of the publicly available transcriptomic profile of FReP cells in comparison with that of induced pluripotent stem cells (iPSCs) to confirm the non-tumorigenic nature or FReP cells is independent of the sex and age of their parental fibroblasts (AIM 1) and track the transcriptomic alteration of bioenergetic-related genes during FMOD reprogramming to gain insight into a novel strategy to advance this technology (AIM 2). Completing these AIMs will enrich our knowledge about cell fate determination and reprogramming, and tumorigenesis, which will directly benefit the development of FReP cell-based therapies for the craniofacial musculoskeletal reconstruction and regenerative medicine in general.